Biospecimen Core Resource (BCR) services

The contractor is responsible for establishing and maintaining a Biospecimen Core Resource (BCR) with biospecimen and data management services for the Cancer Moonshot Biobank (CMB) to facilitate research through collection and distribution of biospecimens from a diverse participant population recruited at multiple medical institutions throughout the United States. The services shall be provided in close collaboration with the National Cancer Institute (NCI) and other CMB stakeholders to manage this unique biospecimen resource so that longitudinal biospecimens from the same individual are appropriately collected, tracked, prioritized, analyzed, stored, and distributed. Key goals include ensuring that standards are developed, implemented, continually improved, and maintained for all aspects of cancer-related annotated biospecimen management and processing.